Addressing biomedical challenges with computational mechanics and big data

PROJECT SUMMARY
The objective of this project is to develop better algorithms for molecular
mechanics and flexible docking, incorporate new data, and use the methods to
expand the set of three-dimensional atomic models of bio-macromolecules and
their ligand complexes with predicted parts and homology models. These
models will be used to identify new therapeutic candidates and predict
mechanism of action of drugs. Since 2007 we collaborated and published with
over sixty research laboratories and used structural models to understand
biological function and therapeutic action. We will work in close collaboration
with several laboratories at Skaggs School of Pharmacy and Pharmaceutical
Sciences, UCSD, UCSD Medical School, Bioinformatics and Systems Biology
Program at UCSD and several US Institutions. The SSPPS collaborators include
Tracy Handel (chemokine receptors), James McKerrow (head of CDIPD center),
Larissa Podust (crystallography, CDIPD), Conor Caffrey (schistosomiasis,
hookworms), Jair L. Siqueira-Neto (HTS core, trypanosomiasis, leishmaniasis,
antivirals), Anjan Debnath (amebiasis), Carlo Ballatore and Dionicio Siegel
(medicinal chemistry) . Nuno Bandeira and Pieter Dorrestein (NIH/NCRR Center
for Computational Mass Spectrometry), will help with incorporating or generating
mass spectrometry data. We will also work on new treatments for several
diseases, molecular mechanisms of action, and probes for new disease related
pathways with the laboratories from UCSD Health Sciences Departments (Silvio
Gutkind, Joseph Califano, Don Durden, Nunzio Bottini, Olivier Harismendy -
oncogenomics, Pavel Pevzner, Lev Tsimring) and several US laboratories (Mark
Yeager, UVa, Irina Artsimovich, OHSU, Andrei Osterman, SBP-
Med.Res.Institute, Eric Debler, Jefferson Uni.). Better methods, better models,
better data will help with new probes for disease-related pathways, drug
repurposing and designing new drug combinations, understanding drug-
resistance mutations, and understanding multi-target drug pharmacology. We
will make all the data and programs produced during the project publicly
available.

Public health relevance
PROJECT NARRATIVE The project will address open biomedical challenges in the area of disease treatment, mechanism of a disease, and complex interactions of therapeutics with molecular structures of human cells at atomic level. We will develop more powerful methods for modeling disease-relevant large biological assemblies, docking and screening for new targets to cure deadly human diseases.